SYSTEMS PLANNING SERVICES FOR NCI

Provide systems planning support to the National Cancer Institute in documentation and presentations, conferences and meetings, and planning (both required reports and individual program plans).